Stephenson Cancer Center - Cancer Center Support Grant - Understanding Key Factors and Processes Affecting Follow-up of Abnormal Cancer Screening Tests in American Indian Patients

Project Summary/Abstract
American Indian populations in the United States (US) experience major disparities compared to the general
population in incidence and mortality for cervical cancer (CC) and colorectal cancer (CRC). Highly effective
evidence-based screening tests exist for CC and CRC, but in order to be effective diagnostic testing must be
completed when the initial screening result is positive. In Indian Health Service, Tribal and Urban Indian (ITU)
healthcare facilities in Oklahoma, initial screening for CC includes Papanicolaou (Pap) smear testing either
alone or with high-risk human papilloma virus (hrHPV) co-testing. Initial screening for CRC typically relies on
stool-based tests (e.g., fecal immunofluorescence testing testing). Unfortunately, many persons with positive
initial screens do not receive timely diagnostic colposcopy after a positive CC screen or colonoscopy after a
positive stool-based CRC screen, likely contributing to worse outcomes. A clear understanding of the factors
and processes of care that impede or facilitate follow-up to diagnostic testing after CC or CRC screening in
American Indian persons has never been reported. Completion of diagnostic follow-up is influenced by
individual-, structural-, and system-level factors, including social determinants of health (SDOH). Economic
deprivation, lack of health insurance, geographic travel barriers, distrust of the healthcare system, lack of
knowledge and communication about screening procedures, and others may impede diagnostic testing. This
study uses a multilevel approach to identify barriers and facilitators to diagnostic colposcopy and colonoscopy
among American Indian patients in Oklahoma who receive care in ITU clinical settings. The study has the
following specific aims: 1) To conduct semi-structured interviews of patients, providers, staff and administrators
at ITU clinic facilities, and, when applicable, providers and staff at non-ITU specialist facilities; and 2) To
understand clinic flow processes and the organizational climate for process improvement from initial screening
through completion of colposcopy or colonoscopy in ITU clinic facilities. This study will identify critical points in
the process of healthcare in which navigated intervention would help ensure smooth progression from
screening to diagnostic testing. Detailed flow maps will be created for each cancer for each participating ITU
site and specialist practices performing diagnostic testing. To assess organizational climate and practice
readiness for improving diagnostic testing, the Change Process Capability Questionnaire will be administered to
each ITU practice. Taken together, Aims 1 and 2 set the stage for navigation-based implementation studies to
improve completion of diagnostic testing.

Public health relevance
Project Narrative The reduction of cancer health disparities for screen-detectable cancers, such as cervical cancer and colorectal cancer, is a significant priority for American Indian communities. This project features a multilevel approach to systematically identify barriers and facilitators to receipt of diagnostic colposcopy among American Indian women with positive initial cervical cancer screening results, and receipt of diagnostic colonoscopy in American Indian men and women with positive initial stool-based colorectal cancer screening results. Findings will provide essential information for extending navigator-based screening programs to include diagnostic follow-up testing.